Investigating the role of a conserved serine/threonine kinase, SAX-1, in higher-order dendrite pruning

PROJECT SUMMARY
Neurite remodeling is a highly conserved process that refines and establishes a mature nervous system. A failure
in neurite remodeling leads to neurological and neurodevelopmental disorders. While developmental dendritic
pruning, a means of neurite remodeling, has been extensively studied, the cell-biological mechanisms that
control pruning remain poorly understood. Specifically, there is a fundamental gap in understanding how neurons
can selectively prune specific dendritic branches while leaving sister branches intact. The long-term goal is to
identify and understand the cell-biological mechanisms that direct branch-specific pruning. The nematode
Caenorhabditis elegans inner labial 2 (IL2) neurons, upon entering a developmental diapause, extend a
stereotypical dendritic arbor that is pruned when development is resumed – leaving primary dendrites intact. The
stereotypic remodeling of IL2 neurons allows experimental access to elucidate the cell-biological mechanisms
that confer selective pruning. The central hypothesis is that SAX-1, an evolutionarily conversed serine/threonine
kinase, functions in a molecular pathway that links calcium signaling to cytoskeletal dynamics in higher-order
dendrite branches to direct selective pruning. The rationale for this proposal is that studying the role SAX-1
during IL2 remodeling will offer a framework to understand how local regulation of the cytoskeleton confers
branch-specific pruning. The central hypothesis will be tested by the following specific aims: 1) determine how
SAX-1 directs pruning of higher-order IL2 dendrite branches; and 2) identify the genetic pathway in which SAX-
1 acts to regulate the cytoskeleton during pruning. The research proposal is innovative because it will 1) be the
first to establish C. elegans as a model system for studying pruning, 2) elucidate a novel role for SAX-1 in
dendritic pruning, and 3) determine how the cytoskeleton is locally regulated during pruning. The proposed
research is significant because elucidating the fundamental cell-biological mechanisms of branch-specific
pruning will significantly advance our understanding of developmental neurite remodeling. This understanding is
a critical to inform us about how neurodevelopmental processes go awry in disorders such as Down Syndrome.

Public health relevance
PROJECT NARRATIVE The cytoskeleton is implicated in dendrite pruning, a developmentally and environmentally regulated process that allows refinement of the nervous system. Pruning defects have been associated with neurological or neurodevelopmental disorders, such as Autism Spectrum Disorder or Down Syndrome. This project aims to study the role of SAX-1, an evolutionarily conserved serine/threonine kinase, as a cytoskeleton regulator that mediates higher-order dendrite pruning in C. elegans; this project will increase our understanding of fundamental processes that shape the nervous system and could illuminate how neurodevelopmental diseases arise.